EFFECTS OF PUBERTAL TIMING ON BODY COMPOSITION AND GROWTH

Accurate analysis of the components of body composition can lay the ground work for the comprehension and prevention of various disease processes; however, such data are lacking for children, especially by the more accurate 4-component model We will specifically address the role of gonadal steroid hormones by comparing groups with deficiencies of these hormones (e.g., Turner syndrome, C DGA) or previous excessive levels (precocious puberty) to normally growing children, also taking into consideration nutrition and changes in GH and the adrenal steroids. We continue to enroll subjects.